Mechanistic Investigations on Anchored Substrates and Inhibitors for Carrier Protein Dependent Acyl-Homoserine Lactone Synthases.

PROJECT SUMMARY
Gram-negative bacteria count N-acyl-L-homoserine lactone (AHL) autoinducer signals to estimate local
population densities through a cell-counting mechanism called quorum sensing (QS). To facilitate QS, AHL
synthases recognize specific Acyl Carrier Protein (acyl-ACP) and S-adenosyl-L-methionine (SAM) substrates
to generate specific AHL signals for the bacterium. Bacteria counts these AHL signals as ‘votes’ to determine
if their local population has reached a sufficient quorum to collectively regulate gene expressions such as
bioluminescence, and virulence. QS inhibitors are therefore useful leads as antivirulence compounds and as
chemical probes to investigate social behavior in bacteria. Over the past twelve years, our group has
developed a versatile experimental toolkit to investigate the mechanisms of quorum signal synthesis. Our
long-term goals are to a) establish the molecular determinants that dictate fidelity in substrate recognition and
AHL signal synthesis and b) explore mechanistic differences between AHL synthases and acyl-ACP utilizing
enzymes to develop QS-specific inhibitors and c) evaluate the merits and demerits of ligand anchoring
approaches in developing protein-free substrates and small molecule inhibitors for ACP-dependent enzymes.
Enzymes that react with acyl carrier protein substrates typically involve a series of carefully orchestrated
protein-protein interactions to bind and react with their cognate substrates. As a consequence, protein-free
pantetheine-, CoA-based substrates demonstrate poor reactivity posing barriers to the rational design of small
molecule inhibitors for ACP-dependent enzymes. To address this challenge, we recently embarked on a
mechanistic study to investigate the extent of ACP-enzyme protein-protein footprint for a series of substrates
bound to 3-oxoC6-ACP preferring EsaI and C8-ACP preferring BmaI1 AHL synthases. Our discovery of a
significantly reduced protein-protein footprint from a single hydrogen bond anchor in EsaI has opened up
exciting new prospects for developing small-molecule anchored substrates and inhibitors for ACP-dependent
enzymes. Building upon this discovery, we hypothesize that increasing the number of anchors between the
substrate and enzyme should further reduce the need for protein-protein footprint, enhance the catalytic
efficiencies of protein-free substrates and inform the rational design of small molecule active site specific
inhibitors. This MIRA proposal will take our program in a new direction by integrating chemical synthesis,
structural biology, microbiology, protein biochemistry and mechanistic enzymology approaches to evaluate a
previously untested ligand anchoring hypothesis on both acyl-chain cleaving (AHL synthases) and acyl-chain
modifying (fatty acid biosynthesis) ACP-utilizing enzymes. Our findings will inform the rational design of
pantetheine-based, active site specific inhibitors for medicinally important carrier protein dependent enzymes.

Public health relevance
PROJECT NARRATIVE STATEMENT Research described in this application will establish the structural and molecular determinants of acyl-chain anchors in building protein-free substrates and small molecule inhibitors for carrier protein dependent quorum signal synthases. The acyl-chain anchoring approach should open new avenues for discovering QS specific inhibitors. Small molecules that modulate quorum sensing are promising leads as novel antimicrobials and as mechanistic probes to investigate social behaviors in bacteria.